Developing multiparametric fluorescence microscopy to connect metabolism with cellular manipulations

Project Summary:
Correlating metabolic changes with external or internal stimuli and cellular manipulations in high spatial detail
is important for understanding causation and correlation in biological systems. Especially, direct pixel-by-pixel
correlation of multiple observable quantities, e.g., metabolism, diffusion of proteins, membrane fluidity, is
difficult to observe simultaneously. Connecting these physical and biophysical behaviors across multiple
imaging modalities can enable us to understand how inhibition of one property, e.g. changing the diffusion of
the protein, can influence other properties such as metabolism or membrane fluidity. This type of correlation
and causation-based simultaneous imaging in the same biological system is something that is lacking in
current fluorescence imaging-based systems. Investigation of these properties in high resolution via confocal
and multiphoton fluorescence microscopes enables us to interrogate cellular and subcellular details of these
interactions. The goal of my research program is to create a framework and seamless workflow of imaging
methodology where all of these fundamental properties and interactions can be quantified and correlated at the
native resolution of the acquired image. To do so, we propose combining the phasor approach to Fluorescence
Lifetime Imaging (phasor-FLIM), phasor approach to hyperspectral imaging (sp-phasor) and phasor approach
to Fluorescence Correlation Spectroscopy (phasor-FCS). We will further create an imaging biophysics
research program which combines single-molecule (SM) and ensemble fluorescence experiments in vitro and
in solution to get a deeper detail at the fundamental questions arising from the molecular interactions. Most
imaging approaches are focused on increasing resolution (either in time or space) for structural elucidation.
Our approach towards imaging is fundamentally different because we are focused on understanding the
functional aspects and quantifying physical properties that can be observed using imaging modalities. In the
next 5 years we want to establish the principle of this multiparametric and multidimensional phasor imaging
and apply them to various biological systems, both in cells and in tissues. Our future goal is to combine the
analysis methods developed here with camera-based systems, including light sheet microscopy, and extend
these approaches to a faster instrumentation and eventually to whole-organism imaging.

Public health relevance
PROJECT NARRATIVE The overall goal of this project is to develop an innovative, sensitive, specific, and more accessible spatial method to correlate metabolic changes associated with cellular manipulations. We propose combining multiple phasor approaches - the phasor approach to Fluorescence Lifetime Imaging (phasor-FLIM, for metabolic imaging), phasor approach to hyperspectral imaging (sp-phasor, protein expression/ membrane fluidity) and phasor approach to Fluorescence Correlation Spectroscopy (phasor-FCS, protein diffusion). This method will allow us to connect changes in one dimension (e.g., protein diffusion) to the changes in another (e.g., metabolism) in a pixel-wise manner.